THERAPEUTIC STUDIES OF PRIMARY CNS MALIGNANCIES

The broad, long-term objective of this application is to improve the effectiveness of management strategies for patients with malignant glioma, a disease process that results in 10,000 deaths annually in the U.S. Standard therapeutic approaches with surgery, external beam radiotherapy and chemotherapy have resulted in minimal survival gain and the lethality approaches 100% with average survival ranging from 9 to 18 months. The specific focus of this grant will be to initiate, and carefully analyze data generated from a series of investigational Phase I/II trials in adult patients with malignant glioma. In order to realize meaningful results within a concise time framework, the investigational studies will be performed simultaneously at several Institutions. We intend to perform 2 to 3 trials annually, enrolling between 100-120 patients through the consortium mechanism. All the patients will be evaluated and treated by a multidisciplinary team composed of neurosurgeons, oncologists, radiation oncologists, neuropathologists, neuroradiologists and clinical research nurses, with the data collected prospectively and monitored and evaluated by dedicated data managers and statisticians. In addition to this intense multidisciplinary clinical effort, the consortium arrangement will permit networking of ideas to allow creative cooperation and maintain the highest level of interest in translational laboratory-based clinical research. The consortium agreement will allow sharing of tumor specimens for ongoing and future laboratory-based studies and subsequent clinical correlations as may develop over the period of this grant. It is expected that these correlations, as they develop, will include but not be limited to new developments in drug and radiation resistance, radiation sensitization, induction of apoptosis, differentiation induction and improvements in therapeutic irradiation techniques. The entire effort will be intimately linked with the ongoing interests, needs and support of the Cancer Therapy Evaluation Program (CTEP) and the Radiation Research Program (RRP) of the Division of Cancer Treatment.